An instrument-free malaria diagnostic

ABSTRACT
We propose to develop a sensitive, rapid, and affordable CRISPR-based diagnostic test for malaria
parasites. The assay will be simple to run, require no instrumentation or advanced training, and
be suitable for resource-limited regions. In the Phase I, we will design and optimize our multi-
chambered FAST-CRISPR diagnostic using cultured parasites and plasmid DNA targets. Later in
the Phase I or in follow-up studies, we will provide diagnostic kits to laboratories in endemic
regions for beta testing. In Specific Aim 1, we will optimize the selection of oligos used in
isothermal amplification of targeted regions and optimize the lysis process to expose the DNA.
Because reactants from one step of the process flow into the next chamber, we will ensure that
buffer compositions are compatible. In Specific Aim 2, we will optimize the CRISPR/Cas12a
reactions for activation of the endonuclease activity upon sensing the target sequences. During
this Aim, we will assess the use of multiple targets and determine assay specificity and sensitivity.
In Specific Aim 3, we will develop the configuration of the FAST device and plan future
manufacturing scale-up.

Public health relevance
Narrative The gold standard of malaria diagnosis is microscopic analysis of Giemsa‐stained blood smears. Highly trained microscopists can detect about 3 parasites per microliter of blood. A large number of molecular diagnostics are in use and in development with varying degrees of sensitivity and quality control. PCR‐based methods can be more sensitive but require the use of relatively expensive reagents and equipment. The ability to detected low levels of parasitemia (below 3 per l) and identify the species of parasite is key to early treatment and surveillance efforts. There is a great need for inexpensive and instrument‐free diagnostics that can detect low level parasitemia. In previous studies, we have developed a multi‐chambered FAST diagnostic device that is pre‐loaded with lysis, amplification, and CRISPR/Cas12a reagents for the detection of several pathogens. The diagnostic does not require electricity, instruments, or highly trained personnel and is designed for point‐of‐care or field diagnostics. We propose to adapt this novel device for sensitive detection of malaria.